Metabolomic interrogation of gut mechanosensing in Drosophila

Project description
Gut epithelium is the principal site in which neural, immune, microbial and dietary factors interact.
These multi-system interactions critically regulate whole-body physiology including metabolism,
immunity, and neurodegenerative diseases. Gut epithelium is exposed to a myriad of mechanical
forces that are generated by gut peristalsis and food passing. These forces include shear stress,
stretch, and compression. Despite growing interest in mechanobiology, mechanisms of gut
mechanosensing and its effects on physiology and diseases remain largely unexplored. In this
project, we explore the impact of gut mechanosensing on metabolism and aging-related dysplasia.
The adult Drosophila midgut has emerged as a simple but robust genetic model system for
investigation of gut growth and physiology. We have recently begun to elucidate the cellular and
molecular mechanisms of gut mechanosensing by showing that shear stress could activate
enteroendocrine cells through the transient receptor potential A1 (TrpA1) ion channel. Moreover,
disruption of TrpA1-mediated gut mechanosensing could significantly impact intestine stem cell
proliferation. In our pilot study, we have made novel and exciting findings that many gut
metabolites including lipids are altered in TrpA1 mutants. In this collaborative project, we will
synergize our expertise on gut mechanobiolgy and state-of-the-art metabolomic analysis, and
combine it with the power of Drosophila genetics, to determine the impact of gut mechanosensing
on systemic metabolism in intact tissues. We also propose to define the signaling mechanisms
that link gut mechanosensing to aging-related dysplasia. Completion of this project will provide a
conceptual advance of how gut mechanosensing could play a role in metabolism and aging. Given
that each cell type in the Drosophila gut epithelium has conserved functions with its mammalian
counterpart, we further expect that our results could provide some insights on gut mechanobiology
in mammals.

Public health relevance
Public health relevance In addition to its nutrient-absorption functions, the gut epithelium is the site in which neural, immune, microbial, and dietary factors interact. Through these interactions, the gut could regulate whole-body physiology ranging from metabolism, immunity to cognition. One important but unsolved problem is how mechanical forces naturally present in the gut could regulate the physiological functions of the gut and other tissues. In this collaborative project, we leverage the power of the model organism Drosophila and combine it with the state-of-the-art metabolomic approaches to explore the novel role of gut mechanosensing in metabolism and aging.